CRCNS: Investigating Brain Dynamics through the Lens of Statistical Mechanics

Synaptic dysfunction has been hypothesized to be one of the earliest brain changes in Alzheimer’s
disease (AD), leading to hyper-excitation in neuronal circuits. However, network changes related to age
and sex tend to overlap with disease neuropathology, increasing the difficulty of separating
disease-specific alterations from those related to normal aging trajectories in males and females. Indeed,
AD disproportionately affects women, who comprise two thirds of all persons diagnosed with AD
dementia.
Leveraging resting state fMRI connectome and diffusion MRI-derived structural connectome, we will use a
novel hybrid resting-state structural connectome (rs-SC) to study excitation-inhibition balance. Recently,
using a group of cognitively normal APOE-ε4 carriers and age/gender matched non-carriers we
demonstrated a sex-by-age-by-phenotype interaction, with significant hyperexcitation with increasing age
only observable in women, but not in men. Further, hyperexcitation in female carriers began to exhibit at
age 50 in the anterior cingulate, parahippocampal gyrus and temporal lobe regions, and the degree of
hyperexcitation is linked to compensatory recruitment of neuronal resources during a spatial learning
memory task.
In this proposal, we will characterize 1) sex-specific normative trajectories of excitation-inhibition balance
using the Human Connectome Project (HCP) data, and 2) altered excitation-inhibition balance in
abnormal aging using the Alzheimer’s Disease Neuroimaging Initiative (ADNI) data, as well as 3) further
test and validate our hyperexcitation framework in longitudinal mouse models of AD.
RELEVANCE (See instructions):
In this proposal, we will develop novel computational tools to characterize hyper-excitation patterns in
aging and Alzheimer's Disease and validate our hyperexcitation framework on human data (ADNI and
HCP) as well as longitudinal mouse models of AD. This will significantly improve our understanding of AD
and potentially accelerate the discovery of more robust non-invasive imaging biomarkers of AD.